Transgenerational obesity caused by ancestral exposure to obesogens in utero: changes in germline genomic architecture, roles of gonadal somatic cells, and metabolomic analysis of sexual dimorphism

PROJECT SUMMARY
Studies in animal models have linked direct exposures to endocrine disrupting chemicals (EDCs) with the
onset of disease in descendants of the exposed individuals. Many groups have demonstrated such
transgenerational effects of chemical exposures, which are proposed to be examples of epigenetic inheritance.
Although transgenerational effects have substantial support in the literature, the concept of inheritance in the
absence of DNA sequence changes is controversial because the underlying mechanisms have not been
satisfactorily explained. If we do not know how transgenerational inheritance of environmental exposures is
transmitted, how can we incorporate the effects of these chemicals on disease burden into risk assessment
paradigms that adequately protect public health? How can we determine which chemicals may have
transgenerational effects? We have developed a transgenerational model for obesity. When pregnant F0
female mice are treated with environmentally-relevant (nM) doses of TBT via their drinking water, increased fat
accumulation can be detected in at least the next four generations of descendents (the F1-F4 generations),
even on a low-fat diet. Male F4 descendents of pregnant F0 dams treated with TBT throughout gestation
developed a transgenerational “thrifty phenotype”: they were resistant to fat loss during fasting, rapidly gained
weight when dietary fat was increased modestly and retained this fat despite being returned to a normal, low-
fat diet. Our published and preliminary results led us to propose a new model for transgenerational inheritance
- that prenatal TBT exposure altered chromatin structure and accessibility, leading to regional changes in
blocks of methylated DNA and differential expression of important metabolic genes, including the satiety
hormone, leptin. We propose a comprehensive series of experiments designed to test the hypothesis that TBT
induces transgenerational obesity by changing chromatin structure which is transmitted via the germ cells to
subsequent generations. We propose the following Specific Aims to test this novel hypothesis: Aim 1: Identify
what changes in genomic structure are elicited by TBT exposure in germ cells and how these are transmitted
down the generations. Aim 2: What is the role of gonadal somatic cells in the transgenerational phenotype. Aim
3: What changes does ancestral TBT exposure elicit in the metabolome and can these be used to determine
why the transgenerational obesity phenotype appears to be male-specific? Delineating these molecular
mechanisms will greatly our knowledge of gene-environment interactions, should lay the groundwork for risk
assessment that includes the contributions of transgenerational effects and will provide insights into how
obesity can be prevented and the obesity epidemic curtailed - an important and timely public health issue.

Public health relevance
Obesity is a major public health problem. We propose to elucidate how the effects of prenatal obesogen exposure are transmitted, leading to a transgenerational thrifty phenotype. The successful completion of this research will make important contributions to understanding epigenetic transgenerational inheritance, how obesity is transmitted down the generations and will provide insights into how obesity can be prevented and the obesity epidemic curtailed.